ABT 378/RITONAVIR IN COMBINATION W/ REVERSE TRANSCRIPTASE INHIBITORS

To study the safety and tolerability of ABT-378/Ritonavir in combination with reverse transcriptase inhibitors in antiretroviral naive HIV-infected patients.